ERC Einstein-Rockefeller-CUNY Center for AIDS research

PROJECT SUMMARY
ERC-CFAR: OVERALL
As the HIV research community and public health systems implement the vision of Ending the HIV Epidemic
(EHE), Centers for AIDS Research (CFAR) play a crucial role leading the trans-institutional and interdisciplinary
research efforts needed to achieve this goal. We successfully filled a vacuum in New York City, a continuing
epicenter of HIV infection previously lacking a CFAR, by creating the Einstein-Rockefeller-CUNY CFAR (ERC-
CFAR). The ERC-CFAR brings together and synergizes the complementary expertise and resources of
researchers from a strong basic and clinical research institution linked to a health system which treats >6,200
people with HIV, the Albert Einstein College of Medicine (Einstein); a globally pre-eminent basic science
institution, Rockefeller University (Rockefeller); and a strong public health/implementation science institution,
CUNY School of Public Health/Hunter College (CUNY), while establishing linkages to the NYC Department of
Health and Mental Hygiene. Our vision is for the ERC-CFAR to serve as a catalyst to create innovation and
contribute to EHE by breaking down institutional and disciplinary silos in our complementary basic, translational,
clinical, epidemiologic, behavioral, and implementation research programs to accelerate development of new
therapies, assess and overcome barriers to acceptability, uptake, and adherence, and prevent and cure HIV
infections. The success of the ERC-CFAR Cores, SWGs, and infrastructure in amplifying the research
productivity of our three institutions is illustrated by a >30% increase in our OAR FRB from ~$34 million in FY15
to ~$44.6 million in FY20 and the publication of >1,250 papers by ERC-CFAR investigators. Our ESIs obtained
~$20 million of external grant funding, including ~$7.5 million in NIH grants catalyzed by ~$500K we awarded
for 14 pilot grants, a >16-fold return on investment. We also integrated the concerns of our community members,
including PWH, into our strategic planning process by organizing a novel, highly trans-institutional and
interdisciplinary Scientific Working Group (SWG), with greater than 30 members focused on our community’s
priority research area, HIV and Mental Health. In this renewal, we propose to build on our accomplishments to
further catalyze research to end the epidemic through these Specific Aims: 1) To assemble transinstitutional,
interdisciplinary, community-inclusive ERC-CFAR research teams to develop and implement new strategies to
reduce HIV transmission, improve prevention and treatment, promote sustained viral suppression, and eradicate
HIV reservoirs; 2) To increase the impact of our research through the cutting-edge services of our Biomarkers
and Advanced Technologies Core, Behavioral and Implementation Science Core, and Clinical and Translational
Science Core; 3) To mentor the next generation of HIV investigators, recruit established non-HIV investigators
into HIV research, and forge new collaborations across Einstein, Rockefeller, and CUNY, other NIH-funded
centers, regional academic centers, our public health departments, and community partners to support an
innovative EHE agenda through the Developmental Core and current HIV & Mental Health and future SWGs.

Public health relevance
Project Narrative To serve as a catalyst to generate knowledge and translate it into successful strategies to prevent, treat and cure HIV infection, we organized the Einstein/Rockefeller/CUNY-Center for AIDS Research (ERC-CFAR). The ERC- CFAR brings together a highly synergistic partnership of complementary resources by linking a strong basic and clinical research institution `treating a large patient base of people with HIV (Einstein), a globally pre-eminent basic science institution (Rockefeller), and a strong public health/implementation science institution (CUNY) to energize and mobilize our complementary basic, translational, clinical, epidemiologic, behavioral, and implementation research programs to attain our shared goal of Ending the HIV Epidemic.